Modulation of Neuronal Oscillations

Inter-individual variability is a common observation in studying neural systems but is often ignored in favor of
developing a general understanding of properties and responses that are the mean across individuals. This is
because we accept that neural circuits should produce stable, robust, and consistent activity, characteristic for
each behavioral context. All neural activity results from ionic currents that shape the outputs of individual
neurons or produce synaptic interactions. However, within the same neuron type, these currents and the
channels that underlie their expression show considerable variability across individuals. It remains unclear
how neurons with variable levels of ionic currents and synaptic interactions could produce consistent circuit
output activity with low inter-individual variability of output attributes. The inter-individual variability of ionic
currents is not a static problem, as neuromodulators tune those currents, thereby providing flexibility to neural
circuit activity and behavior. While neuromodulation itself can be a source of inter-individual variability,
functional circuit output should not only be similar across individuals at some basic level but should also
respond similarly to neuromodulators that shape it into different modes of operation, adaptive to different
behavioral contexts. While the role neuromodulators play in providing flexibility of circuits in individuals is well
studied, the role of neuromodulation in producing consistent functional circuit output across individuals is not.
Multiple neuromodulators act on a neural circuit at the same time. Such comodulation is understood to
enhance flexibility by increasing the number of possible circuit states. We propose that comodulation with
excitatory modulators that have convergent cellular effects promotes consistency and robustness of circuit
output. An increase in the number of circuit elements that are targeted results in more consistent overall circuit
activation, and an overall increase in excitability pushes individuals closer to shared upper boundaries of
neuron and synapse activation. We will test this hypothesis in the stomatogastric nervous system, which has
been instrumental in establishing the general organizing principles of convergent and divergent comodulation
and is an ideal testbed for understanding neural circuit dynamics. We will use electrophysiological methods to
determine the effects of single and multiple neuromodulators on individual circuit components, circuit
operation, and output activity. We will apply different sequences of increasing numbers of modulators, either
with converging or diverging cellular and synaptic actions, and determine the effects on inter-individual
variability and mean similarity of circuit output attributes. In parallel, we will use biophysical approaches,
computational modeling and mathematical analysis to understand the underlying cellular and ionic
mechanisms in circuit components that account for consistent circuit output. This work will produce a general
framework to understand the role of comodulation in the production of robust and consistent circuit output.

Public health relevance
We propose that convergent effects of endogenous brain neuromodulatory chemicals may be essential to limiting inter-individual variability of neural systems and shaping consistent neural activity. We develop a mathematical framework for neural output variability and use the crustacean stomatogastric system, one of the best-understood neural circuits for studying neuromodulation, to experimentally explore this hypothesis. Our work will provide insight into general principles of how the nervous system produces reliable activity in face of significant inter-individual variability.